Predoctoral Training in Signaling in Cellular Regulation (T32) INCLUDE Down Syndrome Supplement

SUMMARY
The goal of the NIGMS T32 Predoctoral Training Program in Signaling and Cell Regulation is to prepare
predoctoral trainees for productive research careers in the field of signaling and cellular regulation. The training
faculty mentors consist of an outstanding, internationally recognized group of researchers in the Department of
Biochemistry (BCHM) and the Department of Molecular, Cellular and Developmental Biology (MCDB) at the
University of Colorado, Boulder, who study basic cell regulatory mechanisms through discovery and
characterization of key components in biological pathways. The program mentors students to gain critical
thinking skills and depth in understanding how to assimilate different scientific areas to solve problems in modern
molecular biosciences, and teaches them how to use apply these skills when they enter the biomedical research
workforce. Program elements include program-specific elective courses, an annual Symposium, Supergroup
research conferences, seminars, and journal clubs, together with trainee monitoring through thesis committees
and organizational meetings. These approaches expose students to broad, interdisciplinary scientific areas
through cross-disciplinary mentorship and collaboration; provide them with rigorous training in experimental
design, classical and modern technologies, and data analysis, with high standards for reproducibility; foster a
proactive community effort to promote the recruitment and retention of underrepresented trainees; and support
students’ progress and ability to work in teams in an inclusive environment through all aspects of their training.
Coursework on responsible conduct of research instills students with an awareness of norms and expectations
for conducting research with high ethical standards. Professional development and career training workshops
expose students to diverse career trajectories and opportunities, with experiential coaching for planning and
landing employment. By integrating SCR Program- specific coursework and activities with departmental graduate
program requirements, and through mindful and responsive mentoring, the Program creates a thriving
collaborative and interdisciplinary graduate training environment.
The current proposal requests a NIH INCLUDE Down syndrome Administrative Supplement to the
existing parent T32 program. As articulated in the proposal, 15 of the 36 SCR Training Program faculty are
already actively engaged in Down syndrome-related research and training of graduate students and postdocs in
this field. Thus, the SCR Training Program is well positioned, both scientifically and administratively, to oversee
the mentorship of graduate students interested in Down syndrome-related research. This was demonstrated
during our first INCLUDE Administrative Supplement of 2023-2024, when 4 trainees with interests in Down
syndrome-associated cell mechanisms benefited from training in collaboration with Crnic Institute for Down
syndrome research. Therefore, this proposal is perfectly aligned with the NIH INCLUDE Project Research Plan
Component 1: Targeted high risk - high reward basic science studies in areas highly relevant to Down syndrome.

Public health relevance
NARRATIVE The goal of this training grant is to prepare the next generation of scientists who will conduct high quality research and make new discoveries in biomedical sciences. The research focus of students who train in our program is to understand fundamental mechanisms in signaling and cellular regulation, an area which is key to the discovery of new therapeutic treatments for human diseases such as cancer, diabetes, inflammation, heart disease, immunological and neurological disorders, and birth defects, and forms a foundation for modern research in biology and medicine. The purpose of this INCLUDE supplement application to the existing parent T32 program is to enhance the robust environment for training graduate students in scientific areas that are relevant to alterations observed in Down syndrome and its co-occurring conditions.